EVALUATION OF POTASSIUM DEPRIVATION ON URINARY CALCIUM AND PHOSPHATE EXCRETION

This study is to evaluate the interrelationships between dietary potassium intake and the urinary excretion of calcium and phosphate in healthy adults.